Novel polymeric materials with improved durability in the oral environment: tailoring responses to host and bacterial enzymes with anti-proteolytic and ecology-based antimicrobial approaches.

Dental caries continues to be a public health issue, especially more evident in underserved
populations throughout the U.S. Unfortunately, especially with an ageing population, hundreds of
thousands of resin composite restorations are replaced each year due to recurring decay and
fracture. According to a number of cohort studies, the average life-span of this type of
restoration is 10 years or less, depending on the caries risk level of the patient and on the
complexity of the restorative procedure. This proposal represents an effort to develop novel
antimicrobial structures, based on a targeted approach specifically against dysbiotic biofilm.
Bacterial coalescence will be prevented by using GTF inhibitors, made polymerizable by
functionalization with stable methacrylamides. In addition, MMP-inhibiting moieties will be added
to a polymerizable monomer, improving the stability of the collagen in the hybrid layer.
Ultimately, this will save millions of dollars annually and the unnecessary loss of additional
tooth structure that comes with every re-treatment. The proposed approach will improve the
longevity of restorations by: 1. Designing monomers containing known GTF-inhibiting moieties, thus
making them available non-transiently at the surface of restorations. 2.Utilizing polymerizable
functionalities that depart from the water/esterase-labile methacrylates. Methacrylamides are well
known for their resistance to degradation by hydrolysis, and the systems proposed here will also be
stable to enzymatic attack. 3. Incorporating MMP-inhibiting moieties on the methacrylamide monomer
to the used as the adhesive, thus preserving the integrity of the collagen long-term. 4. Testing
the materials in a physiologically relevant environment, mimicking the conditions in the mouth in
terms of mechanical loading, bacterial challenge and presence of saliva.

Public health relevance
With the huge numbers of esthetic direct dental composites restoration being placed every year in the US, enhancements in their reliability and clinical longevity offer significant health care benefits to the general public. The new polymer system we are developing will produce a restorative with the capacity to prevent colonization of mouth surfaces with oral bacteria, and to preserve the tooth collagen component by incorporating compounds capable of inhibiting the action of collagen-degrading enzymes. In summary, this proposal targets host and bacterial enzymes to minimize or eliminate degradation of biomaterials/tissue interfaces over time, resulting in longer-lasting adhesive restorations, including direct composites and indirect crowns and bridges bonded with resin cements/adhesives.